Development of Evidence-Based Practices for the Management of Neonatal Hypothermia in the Newborn Nursery

PROJECT SUMMARY/ABSTRACT
Neonatal hypothermia, defined by the World Health Organization as temperature below 36.5˚C, affects over
20% (>700,000/year) of late preterm and term infants in US newborn nurseries. Despite its prevalence, there is
a significant gap in knowledge regarding the clinical implications of hypothermia in this population. While
hypothermia is associated with adverse outcomes in high-risk groups (premature or very low birth weight
infants admitted to the neonatal intensive care unit), its clinical implications for late preterm and term infants in
the nursery may not be as severe, potentially leading to unnecessary interventions. The proposed research
aims to transform newborn care by investigating the impact of hypothermia on infant outcomes and resource
utilization in the nursery, and by developing evidence-based best practices for its management. This serves as
a foundational step in optimizing the treatment of neonatal hypothermia across US nurseries, which account for
two-thirds of all childhood hospitalizations. Dr. Rebecca Dang is an ideal candidate to lead this research, with a
strong foundation in clinical research and having published studies analyzing the epidemiology, interventions,
and outcomes of hypothermia among ~24,000 late preterm and term infants at Stanford, which have informed
this proposal. In the proposed research, Dr. Dang will spearhead this multi-institutional study of 8 university-
affiliated nurseries within the Better Outcomes through Research for Newborns (BORN) Network. In Aim 1, she
will analyze electronic health record data from these nurseries to assess the relationship between hypothermia
and clinical outcomes and interventions. In Aim 2, she will conduct semi-structured interviews with healthcare
professionals at these nurseries to provide rich data on hypothermia outcomes and factors that influence
management. In Aim 3, she will employ a modified Delphi approach to develop expert consensus on evidence-
based best practices for the management of neonatal hypothermia in US nurseries. Through these aims and
the proposed training activities (advanced coursework, seminars, and structured mentoring from a multi-
disciplinary team of advisors and mentors), Dr. Dang will develop expertise in 1) multi-institution studies,
including data management, study design, and statistical analysis, 2) qualitative research methodologies, and
3) Delphi technique. The findings from the proposed research are expected to lay the groundwork for future
R01-level proposals that will investigate the impacts of hypothermia best practices on infant outcomes and
resource utilization, with an overall goal of advancing high-value care in neonatal hypothermia management. In
summary, Dr. Dang’s successful single-institution studies, outstanding Stanford training environment,
exceptional team of dedicated and qualified mentors, and thoughtful research and career development
activities, will all poise her for success. In addition, this award will enable Dr. Dang to achieve her long-term
career goals of establishing independence as a physician scientist and becoming a research leader in high-
value pediatric medicine.

Public health relevance
PROJECT NARRATIVE Despite affecting over 700,000 (>20%) late preterm and term infants annually during their newborn nursery hospitalizations, management of neonatal hypothermia (temperature <36.5˚C) lacks robust evidence, potentially leading to unnecessary interventions based on concerns extrapolated from high-risk populations (premature or very low birth weight infants admitted to the neonatal intensive care unit). This K08 project aims to close this gap by examining the impact of hypothermia on health outcomes and interventions in nurseries and establishing expert-driven, evidence-based management practices. The successful completion of this research will not only enhance the care of hypothermic infants in nurseries but will also establish Dr. Dang as an independent leader in high-value pediatric medicine.